Time for Better Diagnosis: Measuring Outcomes, Stress and Time proposal (MOST)

Time for accurate and timely diagnosis is critical yet increasingly constrained. It is important for ensuring
patients have adequate time to share their histories, and for clinicians to collect and reflect on patient data, and
communicate and document their diagnostic assessments. Both patients and clinicians report feeling
insufficient time and rushed in their diagnostic encounters, with clinicians increasingly reporting time pressures,
after-hours work, and lack of control over time needed to care for patients and write their notes. High quality
diagnosis for individual clinicians and health systems requires not only adequate time but also the ability to
have feedback from patients to continuously learn about diagnostic outcomes and experiences. A team of
clinicians and health services researchers who have engaged in more than two decades of work studying
diagnostic safety will work with systems engineers to deepen our understanding of relationships between
diagnosis quality (processes, outcomes, communication with patients) and time and stress. We will also study
a natural experiment, comparing diagnostic encounters at two sites, one that allocates 20 minutes (Hennepin
HealthCare) vs. another allocating 30 minutes (Brigham and Women’s) for primary care encounters.
The project will leverage new EMR technologies that can: a) screen patients for symptoms to identify
diagnostic encounters and collect downstream feedback from patients, b) capture detailed timestamp
information recording each keystroke before, during, and after these diagnostic encounters, and c) record and
transcribe clinical encounters and using generative AI technology to automatically produce clinicians’ notes.
Studying diverse clinics at these two sites, the project has the following three specific aims:
1. Identify 400 patients with diagnostic visits and solicit their feedback on diagnostic processes and outcomes.
2. Collect and analyze data examining relationships between EMR-measured time, clinician stress, and
diagnostic outcomes. This includes using large-scale EMR timestamp data from 40,000 visits, deploying a new
Assessing the Assessment tool, the SaferDx tool, and validated MiniZ clinician stress measures.
3. Collect transcripts generated from 100 AI-documentation-recorded diagnostic encounters and conduct
qualitative analysis of diagnostic communication conversations during the visit, as well as evaluate the features
and quality of the AI-generated notes produced by two commercial vendors. Detailed information from each
encounter will permit evaluation of key time relationships (e.g. how far behind in schedule clinician is for that
encounter, after-hours time), rich evaluation of key elements in the clinical assessment (e.g. diagnostic
uncertainty and differential diagnosis, psychosocial issues, don’t miss diagnoses), and correlation with clinician
stress (e.g. burnout, perceived time pressures, cognitive load). Triangulating these data sources and analyses,
the project will advance our understanding of time required to evaluate common symptoms, along with the
quality of these diagnostic assessments and of AI-generated notes.

Public health relevance
Project Narrative Patients and clinicians report feeling insufficient time and rushed in their diagnostic encounters, with both reporting these stresses often compromise the quality of their diagnostic assessments. We have new powerful electronic tools to identify patients seeking diagnostic evaluation of new symptoms, hearing from patients regarding the quality of their diagnostic experience, outcomes, and errors, as well as to measure encounter and note charting time. This project will collect and analyze these data to understand and make recommendations about the time required for high quality safe diagnosis.